Targeted Therapies for Lymphoid Malignancies

PROJECT SUMMARY
Chronic lymphocytic leukemia (CLL) is the most prevalent adult leukemia in the United States and until recently
was treated with chemoimmunotherapy at the time of disease related symptoms. Our team has been a major
contributor to the introduction of the Bruton’s tyrosine kinase inhibitor ibrutinib and humbled by the results with
this agent. Along with this work our recently completed R01 grant for which we seek renewal generated over 30
publications related to mechanism of action, resistance, and toxicities observed with ibrutinib. Additionally, we
identified at least 5 new medications that either are in phase 1 clinical trials for resistant diease or will begin
within the next year. The initial results of ibrutinib therapy in frontline CLL are promising with 92% of patients
being progression free at 5 years and also having immune recovery that diminishes the frequency of infectious
morbidity. However, the great majority of patients still have a small component of minimal residual disease (MRD)
that requires continuous treatment resulting in long-term morbidity that impacts survivorship. When ibrutinib is
discontinuation after extended treatment, it has been observed that some patients rapidly progress whereas
other patients can have durable remissions off therapy. This suggests heterogeneity in the residual MRD tumor
populations among CLL patients on extended BTKi. Aim 1 therefore focuses on utilizing novel techniques
developed by the team to assess the clonal genomic, epigenetic, and biochemical changes in tumor cells from
baseline to an extended time on treatment in responding patients treated with ibrutinib for 3 years. Additionally,
we seek to understand differential immune statuses of patients with detectable compared to undetectable
residual leukemia. Such studies will better guide combination studies in ibrutinib responsive patients to eliminate
these residual cells and allow treatment discontinuation. Aim 2 will support a recently initiated phase 1b clinical
trial with VAY-736 administered to patients who have been on ibrutinib for 1 year or more. VAY-736 is a BAFF-
receptor directed antibody that blocks both BAFF signaling and also has enhanced antibody dependent
cytotoxicity. We have demonstrated a novel BAFF-BCL3 signaling pathway that is active in CLL patients on
ibrutinib and which may contribute later to resistance. Our pre-clinical and translational data support that VAY-
736 is synergistic with ibrutinib in the TCL1 mouse model of CLL, that it blocks BAFF signaling in CLL cells, and
that NK cell function improves with ibrutinib therapy. This trial with ibrutinib followed by VAY-736 will be the first
to give delayed antibody therapy when ibrutinib mediated immune recovery has occurred. If successful, this trial
will provide justification to pursue future strategies allowing discontinuation of ibrutinib. Ultimately, our goal is to
develop combination therapies, such as the one herein with ibrutinib and VAY-736 which produces durable
complete remissions in a defined period of treatment leading to the ability to discontinue therapy and avoid the
need for continuous long-term therapy.

Public health relevance
PROJECT NARRATIVE This competive renewal focuses on characterization of residual CLL cells and immune function of the microenvironment after prolonged therapy with an irreversible Bruton’s tyrosine Kinase inhibitor (BTKi), either ibrutinib and acalabrutinib. Additionally, this project seeks to target these residual cells for elimination clinically using novel immune based therapies such as VAY-736 to facilitate discontinuation strategies of BTKi with significant economic and survivorship benefit to patients with CLL.